Institutional Career Development Core

Contact PD/PI: Brasier, Allan Inst-Career-Dev-001 (002)
INSTITUTIONAL CAREER DEVELOPMENT CORE (KL2) ABSTRACT. The University of Wisconsin (UW)
Institute for Clinical and Translational Research (ICTR) KL2 Program, launched in 2007, has recruited and
trained 82 scholars (55% women, 14% underrepresented race/ethnicity) varied in their identities, discipline,
area of study, and position along the translational spectrum. We appoint three scholars per year for four years
using a combination of internal and external funds. Graduated scholars remain committed to research (90%) in
academics or industry, have been promoted or are eligible for promotion (87%), have successfully competed
for funding as a principal investigator/multiple principal investigator ($225 million) and as a co-investigator
($288 million), and have published prolifically as first/senior author (513) and as a co-author (1,456). In order to
accelerate these and other successes, ICTR has completed an institute-wide strategic plan (Innovation
Scorecard) that serves as a roadmap to use continuous improvement to address ongoing challenges in
conducting efficient, rigorous, and engaged CTR at our Hub—with specific attention to CTR capacity building.
In concert with these continuous program improvement efforts, we engaged a comprehensive KL2 needs
assessment, which recognized key challenges to early-career scientists, including: 1) maintaining work-life
integration, 2) transitioning to independence, 3) promoting diversity in research teams and study participants,
4) designing research for dissemination, and 5) disseminating and implementing research to improve health
outcomes. In the next grant period, we propose to refine our KL2 Program to address these challenges by
achieving the following Specific Aims: 1) Enhance scholar’s vitality by building their capacity to adjust to life
and career stressors, 2) Foster scholars’ engagement of community members in research conduct and
dissemination, 3) Establish longitudinal programming to help scholars incorporate dissemination and
implementation concepts into their research programs, and 4) Disseminate the KL2 Program’s mentorship and
coaching innovations. We have developed a comprehensive plan to increase the recruitment and retention of
scholars from historically underrepresented racial and ethnic groups. We have also designed a rigorous
program evaluation plan to assess influence at all levels of the translational research ecosystem. Program
success will be measured at each level: 1) individual: secure grants and publish work in high-impact journals;
2) proximal: develop and maintain relationships with mentors, mentees, and research teams; 3) institutional
and inter-institutional: form inter-disciplinary scientific teams and transform clinical care and institutional
culture; and 4) societal: revolutionize clinical guidelines and improve health and health equity. The KL2
leadership team’s innovative vision of program enhancement in the areas of mentorship, team science,
leadership, dissemination and implementation, and career resilience will foster and launch a cadre of diverse,
independently funded leaders of CTR who will impact the health of our patients, families, and communities.